Growth plate cartilage stem cells for skeletal repair after injury

Summary
Injuries to the growth plate (GP) remain a major cause of morbidity in children, often leading to angular
limb deformities and even complete growth arrest. Slipped Capital Femoral Epiphysis (SCFE), a transverse
Salter-Harris type 1 (SH1) fracture, where the spherical femoral head of the hip joint slips backwards off the
femoral neck, is a common and debilitating disorder, affecting the hip in children and adolescents and often
culminating in painful arthritis in adults. A vertical Salter Harris type 2-4 (SH2-4) fracture, in which the fissure
plane extends in the metaphysis or epiphysis, leads to an osseous bridge formation in lieu of cartilage, and
angular deformities. This highlights the need for novel therapeutic strategies to prevent bone formation
at the injury site and to allow epiphyseal cartilage to resume growth. One avenue to promote local
cartilage repair, would be through mobilization of resident stem cells in response to injury. Current literature
describes the GP-RZ as a stem cell-rich region, which give rise to the GP appositionally. We recently
discovered that a population of FoxA2+ long-term stem cells (LTSSC) is located in the top compartment of the
RZ. FoxA2+LTSSC have higher longevity, clonogenicity, and are mutually exclusive with the previously
characterized PTHrP+ short-term stem cells (STSSC), located at the bottom of the RZ.
A horizontal SH1 injury successfully heals with hyaline cartilage and involves the expansion of FoxA2+
LTSSC. A large vertical SH4 fracture heals through a "bony bar", while a small SH4 lesion heals with hyaline
cartilage. FoxA2+ LTSSC line the outside of a large SH4 wound, but infiltrate the small SH4 lesion. This
suggests other cell types (e.g osteoprogenitors) may create a physical barrier or a signaling niche, which
hinders FoxA2+ LTSSC healing of large defects. In both injuries, a transient pulse of TGFβ signaling, induced
in cartilage remnants at D1, precedes FoxA2+ LTSSC expansion at D3. This indicates a potential role for
TGFβ, in promoting FoxA2+ LTSSC expansion and differentiation into chondrogenic progeny, for cartilage
repair. These findings will allow us to investigate, for the first time, whether FoxA2+LTSSC contribute to GP
cartilage repair following SH1 and SH4 injuries.
To test this premise, we propose three aims. In Aim 1, we will determine if FoxA2+ cells can contribute
to the repair of a small SH4 lesion, but fail to contribute to the repair of a large SH4 lesion. In Aim 2, we will
determine if TGFβ signaling drives FoxA2+LTSSC migration and differentiation into progeny to accommodate
cartilage repair after SH1 injury. In Aim 3, we will determine if FoxA2+cells transplantation in a large SH4
lesion can prevent formation of a bony bar. Altogether, these results will provide a strong basis for
development of bioengineering strategies for GP cartilage regeneration.

Public health relevance
Project Narrative In this project, the investigators study the role of growth plate stem cells in hopes of gaining insights in the skeletal repair process after physeal injury. The results of the study will help bioengineering efforts directed towards growth plate cartilage regeneration.